Primary Care Research in More Environments in Oklahoma (PRIME-OK)

The Primary Care Research in More Environments in Oklahoma (PRIME-OK) Network Research Hub
is designed to strengthen, expand, and sustain our primary health care research capacity to conduct high-
impact clinical trials and implementation-dissemination research in primary care settings across
Oklahoma. PRIME-OK will include the clinical and community engagement cores of our IDeA-CTR, the
state’s premier primary care Practice-Based Research Network, our recently funded NCI CSRN ACCESS
Hub, the Public Health Institute of Oklahoma and its network of county health improvement
organizations (CHIOs), a state-wide network of Federally-Qualified Health Centers, and the Southern
Plains Tribal Health Board representing the 39 federally-recognized tribal entities in Oklahoma. We will
facilitate clinical study engagement and participant enrollment to support research studies selected by the
NIH within primary care practices that predominantly serve rural and underrepresented patients, extend
and refine our participatory partnership structure and enhance processes of engaging with new primary
health care research partners, in order to further enhance community reach, participant recruitment
capacity, and conduct of proposed research involving underrepresented populations in Oklahoma. We will
also engage collaboratively with the NIH, other Network Research Hub sites, and our Oklahoma partner
organizations to develop one or more novel primary-care focused clinical research studies to be
implemented in the PRIME-OK network.